Novel methods to improve nuclease mediated homologous recombination, Administrative suppl

Project Abstract
In this Administrative Supplement grant application, we request funds to purchase a new cell
sorter (S3e™ Cell Sorter, Bio-Rad). This state of art cell sorter will enable us to evaluate large
size gene knock-in events, including both on-target knock-in, on-target insertion/deletion (indel)
rates as well as potential off-target knock-in and indel events, at the single cell resolution. In Aim
1, we plan to use this cell sorter to evaluate mi-spCas9-v2. In Aim 2, we will use this cell sorter
to evalute mi-saCas9. In Aim 3, we will use this cell sorter to evaluate the efficacy and safety
profiles of miCas9 in clinically relevant applications. As a results, this new cell sorter, once
equipped, will generate more convincing data to demonstrate the advantages of the proposed
miCas9 gene editing nucleases.

Public health relevance
Project Narrative In this Administrative Supplement grant application, we request funds to purchase a new cell sorter (S3e™ Cell Sorter, Bio-Rad). This new equipment will enable us to generate convincing efficacy and safety data at the single cell resolution to demonstrate the advantages of the proposed miCas9 gene editing nucleases.